Performance of colonoscopy in the United States

This agreement is to collect nationally representative based data from health care providers on the provision of colonoscopy in both symptomatic and asymptomatic patients. Colonoscopy is a highly effective clinical preventive service delivered in a variety of ambulatory settings, including both hospital-based and free-standing. Most data on patterns of colorectal screening are self-reported and collected directly from patients;however, this approach limits the level of clinical detail attainable and is subject to reporting bias.